Structure and Function of Direct Delivery Peptides

Summary
Classical concepts of protein folding in membranes were elucidated many years ago and can now be found in
textbooks. Yet, we have observed self-assembled peptide nanopore structures, with many potential applications,
that cannot be fully explained by these classical concepts. The self-assembled helical nanopores, form
macromolecule-sized pores in bilayers with diameters greater than 5 nm. The peptides appear not to be
hydrophobic enough to insert into membrane-spanning structures, yet they do exactly that. We will test the idea
that nanopore stability in the bilayer can be explained by cooperative H-bond networks between peptides, lipids,
and water on the interior of the pore, in addition to classical hydrophobic interactions with the bilayer. The
nanopores we will study are formed through the self-assembly of helical peptides that have been evolved through
synthetic molecular evolution (generations of iterative library design and screening). Elucidating the nonclassical
interactions that govern the self-assembly and stabilization of these nanopores will reveal fundamentally novel
principles of the structure and self-assembly of amphipathic peptides and proteins in membranes and will be the
first quantitative characterization of the role of expansive H-bond networks in the stabilization of transmembrane
pores. In the proposed work, we will quantify i) how peptide nanopore structure and function are affected by
targeted substitution of critical residues in the H-bond network and putative pH-sensor, and ii) how peptide
nanopore structure and function are affected by changes in peptide hydrophobic residues and membrane physical
properties, as defined by lipid composition. Atomistic molecular dynamics simulations will be used throughout
this work to guide the design and the interpretation of experiments. By understanding the sequence-structure-
function relationships of nanopore formation, including pH-sensing and membrane selectivity, we will enable
future nanopore optimization for specific applications. We envision usage in biotechnology and medicine, for
facile protein therapy, drug or macromolecule delivery, anticancer activity, and more.

Public health relevance
Narrative Peptides that self-assemble into macromolecule-sized nanopores in membranes could be useful in many biotechnology applications. To optimize nanopore forming peptides, the interactions that stabilize them must be understood. Synergistic experimental and computational research will reveal new insights into nanopore self assembly.